AIDS GENE THERAPY IN SIV INFECTED MACAQUES

For this study we exposed four rhesus macaque fetuses at 75 days gestation to infectious retroviral vector to evaluate in utero gene transfer as a means of developing rhesus macaques for evaluating gene therapy approaches for AIDS. We had previously shown that the fetal liver of rhesus macaques at 65-75 days gestation contains cell populations having hematopoietic stem cell (HSC)-like qualities, and that the fetal liver expresses the Gibbon ape leukemia virus receptor (glvr) at high levels. With these results we hypothesized that retroviral-mediated gene transfer (RMGT) may be more efficient in developing fetuses, as HSCs are in the microenvironment that promotes cell proliferation - a condition required for RMGT with murine retrovirus-based vectors. The fetuses were separated into two groups, two fetuses per group. Each group 1 fetus was infected with 1.0 mL of culture supernatant from the PG13/LNc8 cell line, which produces infectious retroviral vector at titers of 1 x 106 colony forming units (CFU). One fetus was given the control retroviral vector, LN, while the second fetus was given the retroviral vector containing the trans-dominant negative HIV-1 revA5. Each group 2 fetus was infected with 1.0 mL of culture supernatant containing concentrated retroviral vector pseudotyped with the VSV envelope protein. The first fetus was given infectious retroviral vector having a titer of 1 x 108 CFU, while the second fetus was given infectious retroviral vector having a titer of 2 x 107 CFU. Both group 1 fetuses survived to term and were delivered by C-section 5 days prior to parturition for isolation of cord blood for analysis. The first group 2 fetus died in utero and the second group 2 fetus survived to term. The fetuses that survived have since grown, appear clinically normal and are being evaluated for evidence of stable gene transfer in cell types derived from HSCs.